FLOLAN INFUSIONS IN CLASS 3 AND 4 PRIMARY PULMONARY HYPERTNSION

This study was designed to evaluate the safety of chronic flolan infusions in patients with severe symptomatic PPH, for whom no satisfactory treatment alternative is available.